Research Career Development in Obstetrics and Gynecology

ABSTRACT
The long-standing goal of the Women’s Reproductive Health Research Career Development (WRHR) Program
at Northwestern University Feinberg School of Medicine is to foster and sustain an outstanding mentored
research training program for Obstetricians and Gynecologists and to prepare our WRHR Scholars to become
successful independent investigators in women’s reproductive health research. First funded in 2005, our WRHR
Program has made major strides toward this goal. We have met all WRHR benchmarks, having successfully
trained 12 Scholars who have published 1,291 peer-reviewed manuscripts and received 147 grant awards as
PI, with 50 NIH grants from 12 Institutes (NICHD, NHLBI, NIMH, NIMHD, NCI, NLM, NIDDK, NIAID, NINR, OD,
NCATS, and NIA), including 16 R01s. The Department of Obstetrics and Gynecology (OBGYN) will continue to
coordinate and administer the WRHR Program and leverage the scientific wealth and robust reproductive
research infrastructure at Northwestern. Leadership at Northwestern continues to make strong institutional
commitments to our WRHR Program. Serdar Bulun, MD, the original WRHR Program Director, is Chair of the
Department of OBGYN and PI of this WRHR renewal. Melissa Simon, MD, MPH, is Vice Chair of Research of
the Department of OBGYN and one of our highly successful original WRHR Scholars; she remains as the WRHR
Program Research Director. The Blue Ridge Institute ranks our Department as the third highest for OBGYN NIH
funding in the U.S. Five of our named primary mentors on this application are in the top 50 in NIH OBGYN
funding (Drs. Bulun, Simon, Adli, Kim, Yee). Northwestern operates large, comprehensive, and high-quality
OBGYN residency and fellowship programs that attract some of the best and brightest residents and fellows;
thus, we have an active pool of candidates for WRHR Scholar selection. Our WRHR Scholars have opportunities
to choose among highly competitive clinical research teams or basic and translational science laboratories that
conduct research in the areas of General Obstetrics and Gynecology, Reproductive Endocrinology and Infertility,
Reproductive (Basic) Science in Medicine, Maternal-Fetal Medicine, Gynecologic Oncology, Clinical Genetics,
Diagnostic Ultrasound, Minimally Invasive Gynecology Surgery, Family Planning and Contraception, and Female
Pelvic Medicine and Reconstructive Surgery. Research methodologies and approaches span cutting-edge basic
and translational techniques, and our world class mentors and collaborators include clinical trial and behavioral
intervention specialists, psychometricians, biostatisticians, and experts in a wide range of biomarkers, bio-
behavioral, and social science research approaches. WRHR Scholars will continue to interact with several
Department, Medical School and University-wide Institutes and Centers, including the Center for Reproductive
Science, Clinical and Translational Sciences Institute, the Lurie Cancer Center, the Center for Health Equity
Transformation, and the Institute for Public Health and Medicine, which are all home to large-scale center/multi-
site grants in focused OBGYN areas.

Public health relevance
PROJECT NARRATIVE A severe shortage of physician-scientists persists in the field of Obstetrics and Gynecology (OBGYN), despite a growing number of pressing women’s reproductive health issues that would greatly benefit from targeted research. Since 2005, throughout the first four cycles of the WRHR Program at Northwestern University, we have successfully developed and nurtured an exceptional mentored career development program that facilitates the transition of Obstetricians and Gynecologists into independent investigators. We aim to build on this success, continuously enhancing the program to produce highly successful OBGYN physician-scientists.